A unique peri-hippocampal mast cell population drives neurodevelopment

Project Summary
The etiology of neurodevelopmental diseases such as autism spectrum disorder and schizophrenia is
multifactorial, with increasing evidence indicating a role for immune cells such as microglia and peripheral
immune cells. Understanding how the immune system regulates critical periods in brain development is important
for a thorough comprehension of disease progression. While resident myeloid cells microglia can support cell
genesis, synapse formation, and myelination, less clear is the contribution of peripheral immune cells to these
phenomena. This includes mast cells (MCs), a type of innate immune cell that degranulates to release mediators
including histamine, cytokines, growth factors, and more in the settings of allergy, inflammation, and tissue repair.
We have discovered a robust population of MCs lining the lateral ventricles next to the hippocampus in the rat.
This population rises in number and peaks at postnatal day 7, then decreases so that MCs are undetectable by
week 3, reminiscent of a developmental critical period. The presence of these highly reactive immune cells,
associated with allergic and parasitic diseases, in a tightly regulated developmental space raises questions about
their physiological purpose in this niche at this time. The first two weeks of neurodevelopment mark the beginning
and expansion of hippocampal neurogenesis, axon outgrowth, and synaptogenesis, all of which are impacted
by immune signaling. Additionally, links between diseases with an overabundance of MCs (e.g., mastocytosis)
and autism point to a potential pathological role for MCs in neurodevelopment. This proposal seeks to decipher
the role of peri-hippocampal MCs during a critical period in hippocampal development. Importantly, these MCs
are replicative, unlike most tissue-resident MCs, and do not originate from peripheral bone marrow sources. I
hypothesize that these MCs originate from the embryonic yolk sac and seed the brain in embryogenesis, similarly
to microglia. An inducible Cre fate-mapping system combined with flow cytometry will test this hypothesis in mice
(Aim 1.1), followed by RNAscope for candidate yolk sac genes in rats (Aim 1.2), bringing this investigation back
to our original rat model. Preliminary RNAseq analysis on these MCs uncovered gene ontology terms related to
processes such as neuronal projection and synapse formation, informing our hypothesis that these MCs
participate in hippocampal synaptogenesis. In the preoptic area, MCs alter synaptic patterning via histamine
release, a viable strategy that we will explore by inducing peri-hippocampal MC degranulation and determining
the effect on dentate gyrus dendritic spine density in Aim 2. These experiments will help decipher the role of
MCs in hippocampal neurodevelopment, providing another piece in the puzzle of neuroimmune interactions
during development. Completion of these experiments, as well as mentorship from developmental neuroscientist
Dr. Margaret McCarthy and allergy immunologist Dr. Achsah Keegan, will provide comprehensive training in
neuroimmunology and establish a strong foundation for a physician-scientist career in pediatric neurology.

Public health relevance
Project Narrative Crosstalk between immune cells and brain-resident cells such as neurons and glia occurs both in healthy conditions and during the progression of neurodevelopmental diseases such as autism and schizophrenia. This proposal seeks to understand the role of a unique population of mast cells next to the developing hippocampus and its potential for driving proper neurodevelopment. Unraveling the complexities of these interactions during normal developmental stages can lead to a better understanding of how neuroimmune interactions can be altered in disease.